Perinatal PFAS Impact Children's Development: Examining the Roles of Placental Functional Multiomics and Protection by Maternal Exercise

PROJECT SUMMARY
The perinatal period is well-recognized as a critical developmental window where organ systems are rapidly
growing and tuning their functional programs. This is also a time when environmental exposures can have
profound and long-term impacts on health if they disrupt these processes. Per- and polyfluoroalkyl substances
(PFAS), a family of synthetic chemicals characterized by strong carbon-fluorine bonds, are of particular
concern given their ubiquity in consumer products and their resistance to degradation. Exposures to PFAS
prenatally are known to influence health outcomes, however the mechanisms that link prenatal PFAS to fetal
and offspring outcomes are still unclear and likely includes perturbations to placental function. Similarly, while
the first years of life are critical windows for growth and development, the effects of PFAS exposures
postnatally are poorly understood due to the scarce literature, the lack of longitudinal studies and the difficulty
in collecting biological samples from infants and children. Our team has gathered novel preliminary data and
has thus far demonstrated that prenatal PFAS are associated with differences in the placental DNA
methylome, with lower offspring body weight and fat mass during the first 6 months postnatally, and with
poorer cognitive and language development at 12 months. Importantly, preliminary data also suggest that
prenatal (maternal) physical activity is associated with a reduction in prenatal and umbilical cord serum PFAS
concentrations. Taken together these results uniquely highlight that prenatal PFAS concentrations are
associated with placental -omic responses and child health and suggest that physical activity may be an
effective strategy to decrease PFAS burden. However, the placental mechanisms leading to such effects and
postnatal PFAS exposures' contribution to these outcomes are not clear. Likewise, the contribution of postnatal
PFAS exposure on children’s growth and development is understudied. Given that human exposures to PFAS
will continue for decades, we plan to leverage three unique existing cohorts and a transdisciplinary team to
address these gaps. This approach will allow for robust investigation of how prenatal PFAS exposures impact
placental molecular regulation, and whether these perturbations are associated with growth and development,
while also quantifying postnatal PFAS exposure (offspring serum at 6 months, 24 months, and 60 months) to
examine the combined impact of pre- and postnatal PFAS on growth and development across the extensive
longitudinal follow-up period (at least 5 visits between birth and 60 months of age). Lastly, we will leverage a
randomized controlled trial of physical activity during pregnancy to test whether lifestyle changes can reduce
prenatal PFAS burden or alleviate the risk for adverse effects on offspring outcomes.

Public health relevance
PROJECT NARRATIVE This proposal brings together a transdisciplinary group of investigators to perform a novel assessment of the influences of prenatal and postnatal per- and polyfluoroalkyl substances (PFAS) exposures on placental function and on children’s health. We propose to measure PFAS concentrations in the placenta and in serum samples of children from infancy through 5 years of age, as well as placental functional genomics. We will characterize the relationships between PFAS exposures, placental function, and children’s growth and neurodevelopment as well as examine the potential protective effects of maternal exercise during pregnancy.